Overcoming obstacles in structural elucidation of B cell antigen receptor assembly and lateral interaction

Abstract
Development of effective adaptive immunity following infection and vaccination requires
recognition of antigens and secretion of antibodies by B cells. T and B cells are the two major
types of lymphocytes in the immune system. T cells can sense MHC-bound antigens by the T cell
receptors (TCRs) and B cells can recognize free, unprocessed antigens by the B cell receptors
(BCRs). Despite the critical importance of BCRs, how BCRs are assembled and regulated remain
unclear. In this application, we propose to overcome certain technical obstacles in our pursuit of
BCR assembly and regulation by engineering appropriate cell lines and using the native
membrane environment for complex formation.

Public health relevance
Narrative B cell activation upon antigen engagement of BCR is very important, but the organization and assembly mechanisms of BCR in resting and activated states are still to be uncovered. Almost all vaccines we receive, especially including the COVID-19 vaccines, are relying (at least partly) on activation of the BCR to produce antibodies to kill viruses. Elucidation of the precise architectures and activation mechanism of the BCR will be critical for the development of highly effective vaccines and immunotherapies that can prevent diseases and control cancers.